PACE-VT: A Non-Invasive, Machine-Learning-Driven Digital Twin Approach for Precise Targeting of Ventricular Tachycardia in Cardiac Stereotactic Body Radiotherapy

Project Summary
Ventricular tachycardia (VT) and ventricular fibrillation (VF) are major contributors to the approximately
300,000 sudden cardiac deaths occurring annually in the United States. VT, particularly when refractory to
ablation and medication, poses a life-threatening risk that necessitates innovative treatment strategies.
Cardiac stereotactic body radiotherapy (cSBRT) offers a promising non-invasive alternative; however, its
success depends on precise localization of the VT substrate for targeted, high-dose radiation delivery. The
PACE-VT (Personalized Automated VT Circuit and Exit Localization) represents a transformative step
forward in the management of VT, particularly for patients who are refractory to traditional treatments. This
innovative research aims to integrate patient-specific computational models derived from CT imaging with
real-time ECG data to enhance the precision of non-invasive VT localization. This integration facilitates
targeted, non-invasive interventions such as cSBRT, offering potential improvements in safety and efficacy
over existing therapies.
The primary objective of the proposed project is to validate the effectiveness of a novel non-invasive
VT mapping methodology that combines detailed structural data from CT scans with functional data from
ECGs. The project seeks to demonstrate that this PACE-VT approach can accurately identify VT substrate
locations, improving the targeting of therapeutic interventions such as cSBRT.
The project will leverage existing datasets from catheter ablation procedures to validate the accuracy
of the PACE-VT approach against clinically-identified VT circuits and exits. Statistical analyses will assess
the spatial concordance between predicted VT substrate and actual VT substrate locations, aiming to
substantiate the model’s predictive power. The project also utilizes advanced image processing techniques,
machine learning models, and personalized heart digital twins to analyze VT circuits and exit sites.
Success in this endeavor could lead to broad adoption of more accurate and patient-friendly
management strategies for individuals with challenging cardiac arrhythmias. This project aligns with the
NHLBI’s mission to foster innovative research and has the potential to significantly improve clinical outcomes
and quality of life for patients with life-threatening heart conditions.

Public health relevance
Project Narrative This project is the first exploration of the Personalized Automated VT Circuit and Exit Localization (PACE- VT), an innovative mapping technique for non-invasive, patient-specific VT treatment for cardiac stereotactic body radiotherapy (cSBRT). By correlating VT circuits predicted from patient-specific CT-based heart digital twins with VT exit sites identified from data-driven ECG-based VT exit localization, this project aims to accurately identify VT substrate locations, enhancing non-invasive VT treatment efficacy. The successful implementation of PACE-VT could significantly improve clinical outcomes for patients with refractory VT, offering more accurate alternative to current existing localization methods.